Liquid chromatography and mass spectrometry instrument system

This instrument application requests funds to purchase a liquid chromatography (LC) / mass spectrometry
(MS) system comprised of a SCIEX 4500 triple stage quadrupole (TSQ) mass spectrometer, Exion AC LC and
autosampler, Peak nitrogen generator, and workstation computer. The proposed instrument will be housed in
in the Saint Louis University (SLU) Department of Molecular Microbiology & Immunology and will be managed
as a critical asset of the ADME/PK Core Services Group of the SLU Institute for Drug and Biotherapeutic
Innovation (IDBI). This core offers access to expert pharmacology-related consultations and wet bench
support to the more than 140 IDBI members engaged in drug discovery for diseases such as cancer; chronic
pain; central nervous system disorders; liver disease; infectious diseases such as hepatitis B, tuberculosis, and
fungal infections; genetic disorders including muscular dystrophy and lysosomal storage disease; and
neglected diseases. Laboratory support is critically dependent on having functional and reliable tandem
LC/MS instrument technology to perform the in vitro assays and in vivo studies that are commonly employed in
the testing funnels of nearly every drug development program. Performance of these functions is currently
dependent on an aging Sciex 4000 instrument system which has been in use for more than 14 years. Not only
is it becoming more difficult to maintain and repair each year, but it also lacks the sensitivity, speed, and other
improved technical specifications provided by newer redesigned instrument systems. The Sciex 4500 also
comes with upgraded software platforms for acquiring and analyzing data. Thus, our primary needs for the
Sciex 4500 instrument system are to ensure continuity and stability and to provide enhanced performance in
support of the ongoing and future needs of our many users, knowing that our current instrument is approaching
a time when it will no longer be serviceable. The university has made a strong commitment to the strategy of
helping its researchers obtain key pharmacokinetic data as evidenced by the recent hiring of a highly skilled full
time doctoral level analytical chemist, Dr. Abdul Mottaleb, who has extensive expertise using LC/MS to detect
a wide variety of analytes. He is supervised by Dr. Griggs, the PI of this application, who is the Director of the
core facility and a co-Director of the SLU IDBI. This application summarizes drug discovery research of 11
users of the current instrument system who will have an ongoing need for accurate and timely high-quality data
from the new instrument. This includes four major users with a combined 7 active NIH awards that are
expected to require over 60% of the instrument’s authorized usage time (AUT). The SLU-IDBI continues to
promote ADME/PK services to new users to maximize their impact measured through increased publications,
patents, and clinical translation of academic research. This new instrumentation system will ensure continued
success of the important facility for the next 10 years.

Public health relevance
Saint Louis University has a critical mass of NIH-funded investigators that have basic instrumentation need for the SCIEX 4500 mass spectrometer with compatible Exion AC liquid chromatography system and nitrogen gas generator. This instrumentation will be used for analysis of samples from studies in which the pharmacologic properties of experimental drug compounds are assessed. The proposed users are all members of a university institute dedicated to facilitating preclinical drug discovery research in fields such as infectious disease, cancer, pain, muscle repair, and immunology.